PHASE II CLINICAL AND PHARMACOLOGICAL STUDY OF PREIRRADIATION TAXOL

This study will seek to determine the response rate of Glioblastoma to a 96 hour infusion of taxol, administered prior to radiotherapy.